Secondary Cervical Cancer Prevention of Vulnerable Women with HPV and HIV Co-infection in India

ABSTRACT
In India, cervical cancer (CC) remains one of the most common malignancies among women, with about 100,000
women diagnosed annually. HIV promotes the progression of precancerous lesions. Among women living with
HIV/AIDS, a lack of Human Papilloma Virus (HPV) screening, coupled with high levels of depressive symptoms and
stigma, along with malnutrition, negatively impact the activation and proliferation of immune cells, further promoting
development of precancerous lesions in the cervix. Programs for women living with HIV (WLH) that include HPV
screening and psychosocial and nutritional support are almost non-existent, and the gap is critical in hopes of reducing
high CC incidence rates. In our recently completed R01 study of 600 WLH in rural India, we assessed the impact of our
“ASHA-Nutrition” intervention, co-delivered by our community health workers (ASHA), and led by nurses, in providing
emotional support, skill-building, nutrition education, and/or protein-enriched food supplements. Our findings revealed
that the nurse-led ASHA support plus protein supplements and nutritional education showed a significant association
with improved CD4+ T cell counts and increased lean mass at 18 months as well as improved depression, social
support and stigma. CC screening of 598 of these WLH revealed 13% had abnormal cervical lesions and 4 (1%) had
squamous CC. Further, our preliminary data suggest that nutritional supplements may be associated with a 40%
reduction in the risk of abnormal cervical lesions. Our stellar team plans to build upon our prior successful model to refine
our newly developed nurse-led, ASHA co-delivered, nutrition-enhanced, ASHA-Health HPV intervention, adapted to the
needs of a high-risk sub-population of women co-infected with HPV and HIV (W-Co-V), and randomized by village
clusters among women treated in antiretroviral treatment (ART) centers in underserved Karnataka, India. With a major
focus on secondary prevention of CC, we hope to mitigate the link between high-risk human papillomavirus (HR-HPV)
persistence (measured as 2 positive tests for the same HR-HPV type, separated by 12 -18 months), risk of CC, as well
as improved health of W-Co-V. We will conduct a parallel-group cluster randomized clinical trial, assessing the efficacy of
our refined comprehensive, ASHA-Health HPV intervention, as it relates to CC prevention, ongoing engagement in the
HIV treatment cascade, and managing nutritional health among 420 high-risk co-infected women, as compared with an
enhanced Standard of Care (SOC+). Our Primary outcome is HR-HPV persistence. Secondary outcomes will be the
improvement in: 1) HIV indices (HIV viral load and CD4+ T cells); 2) Nutritional indices (serum albumin levels, Vitamin A,
Vitamin D, and Iron); 3) Mental health (depression and HPV/HIV internalized stigma); and 4) Engagement in care
(HPV/HIV appointment keeping and ART adherence); all measures will be assessed at baseline, and at 6-, 12-, and 18-
month follow-ups. The ASHA-Health HPV Intervention builds on a highly successful multifaceted US-Indo collaboration
of over 10 years, has a high potential for scale-up in India, and engages HPV co-infected WLH in reducing the risk of CC
as well as improving their health. The success of this intervention can lead to policy development and future
implementation science trials in the prevention of CC among co-infected Indian women.

Public health relevance
PROJECT NARRATIVE Our proposal targets secondary prevention of cervical cancer with the long-term goal of mitigating high-risk HPV persistence, risk of cervical cancer, and improving the health of women co-infected with HPV and HIV. The proposed comprehensive ASHA-Health HPV intervention builds on a highly successful and long-term US-Indo collaboration with a high potential for scale-up in India. Success of this intervention will lead to policy development and further cervical cancer prevention trials among co-infected Indian women.